Identification of cancer neoepitope-specific T cells using novel high-throughput hydrogel based platforms

Abstract
Immunotherapies for cancer, including Adoptive Cell Transfer (ACT), chimeric antigen receptor
(CAR) T cell therapy, and Immune Checkpoint Blockade (ICB), have seen great clinical
success. However, they are still limited by cost, variable efficacy and resistance, and lack of
quality targets. Technologies to track immune responses, and in particular tumor-specific T cell
responses, would help researchers and clinicians to better understand variable responses in
patients, design better targets for therapies, and track patient health outcomes. In this proposal,
we aim to adapt our novel hydrogel-based immune cell expansion system to detect and
characterize rare, neo-epitope specific T cells in the peripheral blood. This platform, termed the
artificial T cell stimulation matrix (aTM), is a hyaluronic acid hydrogel conjugated with signals 1
(peptide-MHC), 2 (anti-CD28) and 3 (cytokine support). In order to create an aTM-based high-
throughput detection system, we will first investigate the effects of physical (i.e. stiffness) and
biochemical (i.e. activation molecules and cytokines) cues of the aTM on the expansion of neo-
epitope specific anti-tumor T cells in mice. We will test the optimized aTM for batched expansion
from bulk murine splenocytes in order to create a high-throughput system. Next, we will develop
a process to detect and expand tumor-associated antigen-specific T cells from peripheral blood
of healthy donors and compare this to current gold standards of antigen-specific T cell
detection. Finally, because disease status may impact our ability to detect rare T cells, we will
verify that the system can be used for detection of neoepitope-specific T cells from the
peripheral blood of melanoma patients. Access to blood from patients will also allow us to
determine how ICB treatment affects the immune response to the tumor by investigation of
expanded neo-epitope specific T cell phenotype and function before and after therapy. The
development of aTM as a high-throughput detection system for neo-epitope, patient-specific T
cell responses will allow pre-clinical and clinical researchers to study immune responses to
cancer and to improve cancer immunotherapies by bringing the power of these therapies to
more patients.

Public health relevance
Characterization of the immune response before, during, and after administration of immunotherapy would allow researchers and clinicians to better understand how patients respond to these therapies and how resistance develops, as well as facilitate more informed decisions about therapy choice, dose, and target. One important marker of the immune response against cancer is the presence of mutated neoantigens in tumors, but a major unmet challenge is the ability to detect immune responses to neoantigens within tumors or in the peripheral blood. The proposed research seeks to apply a novel hydrogel-based platform for high throughput detection and expansion of neoantigen-specific immune responses in tumor- bearing mice and humans.